Facility and Building System Upgrades Support for the Howard T. Ricketts Biocontainment Laboratory

Project Summary/Abstract
The Howard Taylor Ricketts Laboratory (HTRL) is a state-of-the-art Regional
Biocontainment Laboratory on the Argonne National Laboratory (ANL) campus in DuPage
County, Illinois. Located twenty-five miles southwest from the University of Chicago campus,
ANL is a federally (Department of Energy) owned site operated by the University of Chicago
(UCHICAGO LLC). HTRL is a CDC certified facility owned by the University of Chicago and
operated by the Department of Microbiology. Biosafety training and surveillance program
involving classroom and laboratory activities ensures that staff, students, and fellows comply
with state and federal regulations to safely operate facilities and experiments with RG2, RG3
and Select Agent pathogens. The HTRL construction was completed in 2008. Over the last 13
years, the HTRL has hosted research programs studying the bacterial species Yersinia,
Brucella, Coxiella, Rickettsia, Bacilli, MRSA and other ESKAPE organisms, as well as viral
pathogens including low and highly pathogenic influenza, DENGUE and more recently SARS-
CoV2. The facility currently hosts research program on Plague, Anthrax, MRSA, as well as a
Core Research Facility for SARS-CoV2. The HTRL is the largest A-BSL3 holding facility in the
region and regularly supports research from consortium institutions including UIC, Northwestern
U and Loyola U. The HTRL is fulfilling its goal to rapidly respond to research needs and support
biomedical inquiries on emerging and re-emerging pathogens, discovery and testing of new
therapeutics and vaccines. The building has been maintained in good working conditions and
has been in constant use since its construction. However, with the swelling demands for BSL3
and ABSL3 space and research expertise, the development of new technologies for the study of
infectious agents, this proposal is a request (i) to upgrade system and building components for
safe research operations, and (ii) to replace research equipment that have either outlived the
intended useful life or no longer meet facility requirements.